Allergen T cell epitopes during the management of peanut allergic disease

ADMINISTRATIVE CORE
Project Summary
The Administrative Core will ensure that the U19 Peanut Allergy Program's scientific objectives are met by
providing scientific oversight, coordinating data integration, and managing day-to-day administrative and fiscal
requirements. Scientific oversight will include facilitating scientific progress, promoting communication between
key stakeholders, and assisting in the dissemination of research findings to both the scientific and wider
community. The Administrative Core will also ensure regulatory compliance in terms of data sharing, and
protection of human subjects. The leadership team led by Dr. Kwok will work with the Scientific Advisory
Board, and Steering committee to ensure the overall success of the Program through innovation and
collaboration among its members.